Brain Estrogen Regulates Energy and Glucose Balance

PROJECT SUMMARY
Dramatic decline in circulating 17β-estradiol (E2) in post-menopausal women has been associated with
development of obesity and glucose dysregulations. While E2 administration in post-menopausal women
may correct these issues, the estrogen therapy is often associated with side effects, including reproductive
endocrine toxicity and breast cancer. Targeting specific estrogen receptors (ERs) and ER-expressing
populations may produce anti-obesity and anti-diabetes benefits with fewer side effects. We demonstrated
that estrogen receptor-α (ERα) in the ventrolateral subdivision of the ventromedial hypothalamus (vlVMH) is
essential to maintain body weight and glucose balance. Here we seek to unravel the molecular and
neurocircuitry mechanisms for these ERα neurons by testing a general hypothesis that E2-sensitive
ERαvlVMH neurons detect nutritional/glycemic fluctuations, and recruit multiple downstream neural
circuits to maintain energy and glucose homeostasis. The first objective is to determine the glucose and
energy-regulatory effects of the ERαvlVMH-originated projections to a few brain regions, including the dorsal
Raphe nuclei (DRN) and medial posterior arcuate nucleus of the hypothalamus (mpARH). The second
objective is to determine whether two ionic channel genes, namely, Abcc8 and Ano4, regulate the firing
responses of ERαvlVMH neurons to various alterations in blood glucose and/or feeding states; we will also
examine the physiological functions of these channels on whole-body energy/glucose balance. The third
objective is to establish Clic1 as a novel ERα target gene, and to determine whether Clic1 in ERαvlVMH
neurons mediates actions of E2 to maintain energy and glucose balance. Accomplishment of these studies
will unravel ionic mechanisms by which ERαvlVMH neurons detect dynamic changes in energy and glucose
balance, and reveal the ERαvlVMH-originated neural networks that respond to these changes and therefore
restore energy/glucose homeostasis. We will also delineate molecular mechanisms by which E2 regulates
ERαvlVMH neuron functions and energy/glucose balance, and may identify potential targets for treatment of
metabolic disorders associated with menopause.

Public health relevance
PROJECT NARRATIVE The female sex hormone, estrogen, acts in the brain to prevent obesity and metabolic disorders. We found that a group of estrogen-responsive neurons in the brain hypothalamus, namely ERαvlVMH neurons, can sense fluctuations in blood glucose and nutrient levels, and we will examine how these ERαvlVMH neurons integrate estrogen signals and metabolic/nutritional signals to regulate glucose and energy balance.